SIMULATION OF CW ERS SPECTRA OF CU(II)

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. A service request was received from Guosheng Li to use our NLSL program to extract structural information of Cu (II) in his catalyst sample. A hand on instruction was given to him on the usage of the program.